Chromatin modifications that enhance DNA accessibility

Project Summary/Abstract
Chromatin modifications that enhance DNA accessibility: Eukaryotic DNA is tightly packaged into
nucleosomes, which form structural barriers to transcription, yet RNA polymerases effectively read
through chromatinized DNA in cells. Crucial to this apparent paradox are ATP-independent histone
chaperones, which include the heterodimeric FACT (FAcilitates Chromatin Transcription) complex and
the monomeric proteins lens epithelium-derived growth factor (LEDGF) and hepatoma-derived growth
factor 2 (HDGF2). Whereas FACT’s role as a histone chaperone is well-established, LEDGF and HDGF2
were only recently implicated as having histone chaperone activity. Furthermore, LEDGF and HDGF2
have also been implicated in modulating human immunodeficiency virus type 1 (HIV-1) DNA integration
into chromatin, with LEDGF playing a dominant role, but the mechanisms remain unclear. We
hypothesize that: (i) FACT facilitates chromatin remodeling by preferentially binding to nucleosomes
destabilized by post-translational histone modifications, preserving histone-DNA interactions necessary
for nucleosome reassembly; (ii) LEDGF and HDGF2 function as reader proteins, working selectively
through their preferential binding to regions rich in H3K36me2/3 histone modifications, but have
mechanistic similarities to FACT imparted by auxiliary domains; (iii) through their histone chaperone
activity, LEDGF and HDGF2 proteins modulate HIV-1 DNA integration into actively transcribed genes
characterized by chaperone-destabilized H3K36me2/3-rich chromatin. We propose two aims:
Aim 1: Define the differential effects of FACT on the chromatin state To test the hypothesis that
FACT acts as a chaperone by preferentially binding to unwound chromatin intermediates and chromatin
destabilized by histone modifications, we will apply forces with optical tweezers to determine the
equilibrium stability, fluctuational opening rate, and the ability of nucleosomes to reassemble after
disruption in the presence of WT, mutant, and truncated FACT for histones modified through destabilizing
acylation modifications. The results will reveal the extent to which FACT activity can be regulated by
destabilizing histone modifications. Aim 2: Determine the mechanisms by which LEDGF and HDGF2
act as histone chaperones and facilitators of HIV-1 integration. To test the hypotheses that LEDGF
and HDGF2 bind H3K36me2/3-containing nucleosomes and mediate nucleosome disassembly and
reassembly and that LEDGF and HDGF2 direct HIV-1 DNA integration at H3K36me2/3-enriched loci
through their nucleosome chaperone activity at these sites, we will measure the effects of wild type and
mutant LEDGF and HDGF2 on nucleosome stability, dynamics and reassembly, as well as their effects
on HIV-1 integrase binding. The results will determine the mechanism of LEDGF and HDGF2
nucleosome chaperone activity and the role played by histone methylation in regulating that activity.

Public health relevance
Project Narrative Cells in many organisms contain important proteins called nucleosome chaperones that regulate how gene instructions in DNA are copied into RNA before being used to make other proteins. We propose to study this process with tools that let us measure the behavior of single molecules at a time, focusing on how the function of nucleosome chaperones change depending on decorations on DNA-packaging proteins that change with the energy status of the cell. Because cancer cells have more nucleosome chaperone proteins and different decorations on their DNA-packing proteins, and chaperone proteins are involved in replication of viruses, our results may be used in the development of cancer therapies, as well as antiviral therapeutics.